A comprehensive network of neuropsychiatric drugs-genes-phenotypes

Drugs play a dual role in our understanding of neuropsychiatric disorders. First, they are used clinically to alleviate symptoms and (ideally) to reverse aberrant pathophysiology. Second, they provide a molecular

Public health relevance
The project alms to deconvolute mathematically how prescription drugs affect patients with diverse genetic backgrounds¿especially in relation to complex neuropsychiatric disorders, such as autism, schizophrenia and depression.